Structure and mechanism of extrasynaptic GABAA receptors

Project Summary:
Type A γ-aminobutyric acid receptors (GABAA) are pentameric ligand-gated ion channels found
abundantly in the central nervous system. The binding of GABA, the major brain inhibitory neurotransmitter, to
GABAA receptors, accounts for ~30% of the fast synaptic signaling in the brain. These receptors are important
for sensory and motor processing, central autonomic control, and cognition. While much of the research in
GABAA receptor structure and function has focused on the subunit assemblies found at synapses, a tremendous
diversity of pharmacologically important GABAA receptor subtypes are found outside of synapses. The goal of
this proposal is to determine and validate high-resolution structures of extrasynaptic GABAA receptors bound to
distinct drug classes of relevance to neurological disorders, anesthesia, addiction and drug abuse. These
receptors are potentiated by mildly intoxicating concentrations of ethanol, have high affinity for neurosteroids
and are targets of anesthetics, analgesics, and anticonvulsant drugs. In two Aims, I propose to optimize
conditions for expression and purification of defined heteromeric GABAA receptor assemblies, refine sample
preparation for cryo-electron microscopy, collect and process single particle cryo-EM datasets, and build and
refine atomic models of receptor-drug complexes. High-resolution structural information for physiologically
important but understudied subunit assemblies, in complex with allosteric and orthosteric-site ligands will broadly
inform on principles of ligand recognition and subunit assembly.
!

Public health relevance
Project Narrative Extrasynaptic GABAA receptors play an important role in motor processing, sleep-wakefulness, emotion, and cognition. These receptor subtypes bind to diverse molecules and are a promising therapeutic target for neurological disorders such as postpartum depression and epilepsy. Elucidating the detailed structures of extrasynaptic receptors is an essential foundation for understanding the unique properties that govern the diversity of GABAA receptors.